The National Center for Metabolic Phenotyping of Mouse Models of Obesity and Diabetes (MPMOD) at UC Davis

National Center for Metabolic Phenotyping in Live Models of Obesity and Diabetes (MPMOD)
at UC Davis
ABSTRACT—OVERALL SECTION
According to the Centers for Disease Control, more than a third of U.S. adults are obese, suffer related
complications (e.g., heart disease, stroke, cancer), and cost the US economy more than $150 billion annually.
And the facts don’t stop there: recent data from the CDC reveal an increasing incidence of type 2 diabetes,
reaching a prevalence of ~11% of the US adult population today. Genetics, environmental factors, food and
physical activity behaviors, chronic stress, and coincident high-risk morbidities all point to diabetes and obesity
being diseases of heterogenic origin. In this context, advanced research to comprehensively phenotype better
mouse models relevant to the human condition is especially needed to fully understand disease pathogenesis
and mechanisms to inform strategies for curbing this rising epidemic.
Translational research in vivo using genetic, surgical, humanized, and other types of mouse models are
needed especially now to characterize disease pathogenesis, mechanisms, and consequences. These models
need to be relevant to the pathophysiology of human metabolic disease so as to inform more effective
diagnostic, therapeutic, and prevention strategies. To catalyze this effort and accelerate progress toward these
goals, UC Davis proposes the creation of a National Center for Metabolic Phenotyping of Mouse Models of
Obesity and Diabetes (MPMOD). The Center will provide the diabetes and obesity research communities
access to specialized and advanced resources to assess mouse models employing unique, complex, and
hard-to-find tests and procedures. MPMOD users will also be connected to competent, experienced, and
expert consultation and advice on experimental design, test selection, outcomes measures, and interpretation.
The UC Davis MPMOD team has a solid foundation of service to the research community: for the last 10
years, UC Davis served as a flagship in the NIDDK Metabolic Mouse Phenotyping Center (MMPC)
Consortium, providing in vivo services on live mice and in vitro analyses on murine tissue and plasma and
serum to the greater research community. The MPMOD Center at UC Davis will build from those successes
and our strong infrastructure to offer many novel and innovative approaches to tackle new questions in live
mice, drawing upon the larger UC Davis scientific enterprise and core labs to provide the research community
with high quality metabolic, physiologic, and behavioral phenotyping services in vivo to characterize the
heterogeneity, pathogenesis, and consequences of diabetes, obesity, and related metabolic disorders.
The MPMOD Center at UC Davis will consist of an Administrative Core providing administrative, service,
and business oversight for the Center; an Animal Core that will import and provide husbandry, care, and
numerous special services (e.g., SPF husbandry, gnotobiotic mouse management, ABSL3 conditions,
microsurgery capability, necropsy and histopathology) for mice submitted to the Center; a Metabolism and
Metabolic Health Core with significant resources and expertise to offer well-established metabolic phenotyping
tests plus innovative approaches (e.g., PET imaging, continuous glucose monitoring, sophisticated energy
balance measures, xenometabolomics) to reveal subtle shifts in macronutrient metabolism, energy intake and
feeding behaviors, energy expenditure and metabolic efficiency; and a Physiology and Behavior Core with
substantial breadth and depth of expertise and capabilities to provide in-depth assessments of organ and
whole-animal physiology (cardiovascular, gastrointestinal, renal, respiratory, ocular, and neurological) and
neurobehavioral assessment of exercise behavior, sleep, learning and memory, anxiety, depression and
stress, and motor function relevant to diabetes and obesity. Each of the Cores will have a Scientific Leader and
co-Leader, Core Coordinator, and Technical Specialists to conduct experiments. Numerous Scientific
Consultants affiliated with each Core will be available to offer expert advice on experimental design, test
selection, and data interpretation, and provide novel and complex tests and procedures upon request.
In addition to comprehensive tests and consultation, a major strength of the MPMOD Center at UC Davis
will be a close association with internationally recognized assets for production and sharing of novel mouse
disease models. Scientists can of course send in their own mice for testing, but in addition they can order a
mouse model of diabetes or obesity from a repository (e.g., the UC Davis MMRRC, KOMP2 programs) or have
the Center make a relevant mouse model de novo (e.g., genetically-altered, bariatric surgery model) for them.
Services will be offered at reasonable cost to all users who will be afforded equal service priority whether
from inside UC Davis or an outside institution. The Center will reinvest program income to develop new testing
technologies, fund collaborative projects, support fee waivers, and subsidize pilot and feasibility studies. The
Center intends to be an active and engaged member of the MPMOD Consortium by participating in shared
governance of the national MPMOD Program and by providing complementary services to avoid costly and
inefficient overlap between other MPMOD Centers. Finally, the Center will be an active participant in the
MPMOD Vibrant Program and has proposed an innovative partnership between MPMOD Centers and
Hispanic Serving Institutions (HSIs) in the 23-campus California State University (CSU) system.

Public health relevance
PROJECT NARRATIVE The National Center for Metabolic Phenotyping of Mouse Models of Obesity and Diabetes (MPMOD) at UC Davis will serve a primary role in providing unique, complex, and hard-to find tests and procedures for phenotyping live mouse models submitted by investgators from the biomedical research community. The MPMOD Center at UC Davis will also provide expertise, consultation, and advice to researchers on project planning, test selection, and outcomes measures. Further, the Center has proposed a partnership with Hispanic Serving Institutions as a component of the MPMOD Vibrant Program to enable underrepresented PIs and those from small research institutions that traditionally have not received significant research funding and/or have historically served under-represented populations to produce outstanding results and better compete for funding.